iDAPT: Implementation and Informatics - Developing Adaptable Processes and Technologies for Cancer Control

PROJECT SUMMARY
iDAPT Implementation and Informatics - Developing Adaptable Processes and Technologies for Cancer
Control is a developing center with an emerging theme on the use of technologies to support rapid cycle and
real time deployment and testing of implementation processes and adaptations within cancer control. The
Administrative Core will manage the Center, ensure that iDAPT is engaged with “real world” clinical partners,
patients, and families, is well-networked with the Implementation Science Centers in Cancer Control
consortium, and engage in a comprehensive evaluation of Center activities and milestones. The Research
Program will include an Implementation Studies Unit with an initial 2-year pilot study using adaptable
technology to enhance shared decision-making in survivorship care planning for survivors of breast cancer.
The Research Program also includes a Methods Unit with an initial innovation pilot study to test the feasibility
of natural language processing to measure communication patterns pre-implementation and to monitor
implementation fidelity of programs designed to enhance within-team and clinical team-to-patient electronic
communication. The Research Program is expected to complete 8 to 10 pilot studies. In order to foster
research aligned with iDAPT’s theme, we will build and sustain iDAPT’s Implementation Laboratory which
incorporates capacity building and infrastructure for testing the use of technologies to support rapid cycle and
real time deployment of implementation processes and adaptations within cancer control. The laboratory
includes primary care and oncology clinics in our local “Hubs” in southern Appalachia (North Carolina) and the
northeast (Massachusetts) and “Spokes” including over 900 community-based oncology clinics in the NCIs
National Community Oncology Research Program and nationwide Veteran’s Administration clinics. iDAPTs
leadership is a multi-disciplinary team of experts with extensive experience in cancer-focused implementation
science, behavioral science, computer engineering and computer science, clinical informatics, formative
qualitative methods, epidemiology, and biostatistics. The iDAPT Developing Center will be considered
successful if we achieve the following outcomes: (1) a robust, collaborative Implementation Laboratory with
partners who are knowledgeable and experienced with implementation science in cancer control; (2)
completion of 8 to 10 pilot projects related to iDAPTs emerging theme; (3) pilot grantees and lab partners are
prepared to lead investigator initiated studies as a result of capacity building and pilot grant experiences; (4)
junior faculty and underrepresented persons are engaged in all Center activities; (5) The field of
implementation science in cancer control is advanced aligned within iDAPT’s emerging theme; and (6) iDAPT
is part of a new network of ISCCCs who collectively build the field of implementation science in cancer control.

Public health relevance
PROJECT NARRATIVE iDAPT is a developing center that will use technologies to support rapid cycle and real time deployment and testing of implementation processes and adaptations within cancer control. Our team focuses on building capacity among primary care and oncology partners to engage in implementation science in cancer control and to conduct pilot studies aligned with iDAPT’s theme. We have an extensive network of partners concentrated in an the urban northeast and southern Appalachia, as well community-based primary care and oncology clinics throughout the United States. We are committed to the inclusion of junior faculty and under-represented persons in all aspects of iDAPTs developing center.